Core 3: Administrative Core

SUMMARY - CORE 3: Administrative Core (ADM)
The Administrative Core (ADM) of the Program Project in Structural Cell Biology of DNA Repair Machines
(SBDR) will coordinate all administrative aspects of the Program and facilitate interaction among the
Investigators. Our goal is to maintain the SBDR program coherence, focus, and progress to ensure the
successful conduct of the proposed research. Specifically, the ADM Core will provide administrative
infrastructure, ensure milestones are met, and promote interaction and efficient communication among SBDR
Projects and Cores and with the wider DNA repair and cancer research communities. The infrastructure for the
ADM Core is already in place and operating efficiently, having been established during the 19-year history of
SBDR. The ADM Core goals will be accomplished through three Specific Aims:
Aim 1: Provide fiscal management support to the Program.
Aim 2: Ensure effective communication among SBDR Program members.
Aim 3: Monitor SBDR progress and Core Usage.
Management of the SBDR Program will be provided by an administrative structure that formally consists of Drs.
Susan Tsutakawa and John Tainer as ADM co-Directors, together with the Program Administrator and an
Executive Committee comprised of the Project Leaders and selected additional senior co-Investigators. An
External Advisory Board comprised of leading investigators in DNA repair, structural biology, and cancer biology
will annually review the progress of the Program and make recommendations to SBDR PI John Tainer. The
successful operation of the SBDR Program for 18 investigators at 15 institutions depends heavily on excellent
communications and program management capabilities. The ADM Core serves to provide a central point of
contact for all operational matters with in SBDR. This includes providing budget management, coordinating
preparation of annual progress reports, monitoring progress toward overall SBDR goals, maintaining effective
and equitable access to the shared resource Cores, and organizing regular webinars, and annual workshops for
all investigators and SBDR fellows.

Public health relevance
NARRATIVE - CORE 3: Administrative Core (ADM) The overall goal of this Program Project on “Structural Cell Biology of DNA Repair Machines” (SBDR) is to develop detailed structural and mechanistic understanding of the multi-protein machines that carry out DNA repair processes in human cells. These results will advance cancer intervention through the identification of specific ways to control biological outcomes of cellular responses to DNA damage and to exploit specific cancer cell vulnerabilities. This effort involves experimental cycles between structural and functional studies in four Projects with 18 senior investigators. The ADM Core enables this multi-institutional effort by providing overall management of SBDR, facilitating communications, and fostering Program integration.